Eighth Conference on the Neurobiology of Learning and Memory

DESCRIPTION (provided by applicant): The Eighth Conference on the Neurobiology of Learning and Memory is the eighth in a series of conferences organized by the Center for the Neurobiology of Learning and Memory at the University of California, Irvine. The theme of the conference is: Memory and Brain: Basic Mechanisms and Clinical Implications. It will be held in Irvine, California on March 11-14, 2006. The overall goals of the conference are to communicate and discuss recent research findings in five currently important topics in the neurobiology of learning and memory, to stimulate discussion about how basic findings might be translated into therapeutic or other applications, and to educate and inform researchers in the field. The 2006 meeting will include five sessions: 1) Mechanisms for acquisition and maintenance of reinforcement related behavior: Relation to addiction/compulsion, 2) Sensory and perceptual learning, 3) Memory and normal and abnormal aging, 4) Modulation of neuroplasticity and long-term memory, and 5) Molecular and cellular mechanisms of memory. To date, fifteen speakers have agreed to make presentations; we are planning a total of twenty. These speakers are among the world's leading investigators in the topics listed. The conference format emphasizes discussion by all participants. Chairs will be chosen for each session, to lead the interchange of ideas. The general sessions will take place at the Hyatt Regency Hotel in Irvine; a poster session (approximately 100 posters) will be held in the Herklotz Research Facility on the DC Irvine campus. We anticipate an attendance of 350-400 people, including faculty, postdoctoral researchers and graduate students from the U.S. and many foreign countries.